Molecular and Cellular Mechanisms of the Lysosomal Storage Disease Cystinosis

SUMMARY
Lysosomal function is crucial for cell homeostasis, autophagy, nutrient sensing, apoptosis and tissue remodeling.
In lysosomal storage disorders (LSDs), characterized by genetic defects leading to anomalous accumulation of
metabolites in lysosomes, cells are affected by lysosomal malfunction frequently leading to cell death. Cystinosis
is a lysosomal storage disorder resulting from defects in the cystine transporter cystinosin (CTNS). Increased
levels of intra-lysosomal cystine lead to cell malfunction and progressive tissue deterioration, which is especially
manifested in kidneys. As with most LSDs, this leads to a slow but irreversible deterioration, organ dysfunction
and early death. Patients with nephropathic cystinosis develop proximal tubule cell dedifferentiation, Fanconi
syndrome and progressive renal injury, which are not corrected by the current therapy, cysteamine. Thus, cell
malfunction and tissue failure occur despite cystine depletion, suggesting that cystine accumulation is not the
only cause of all the defects observed in cystinosis. We recently revealed a defective mechanism of chaperone-
mediated autophagy (CMA) in cystinosis. Defective CMA is directly linked to human disease, including kidney
pathologies and neurological disorders. CMA defects in cystinosis are caused by mislocalization and
downregulation of the only lysosomal CMA receptor, LAMP2A. Defective CMA activity correlates with high
susceptibility to cell death in cystinosis. Importantly, the defect was not rescued by cystine depleting therapies
supporting that it is independent of lysosomal overload. Our data highlight that CMA impairment is an important
contributor to the pathogenesis of cystinosis and underline the need for new treatments to complement cystine-
depletion therapies. Our research plan aims to elucidate the molecular and cellular mechanisms leading to
abnormal CMA activity in cystinosis. We also propose translational approaches that utilize small-molecule
activators of CMA to improve cellular function in cystinosis. Our Specific Aims are: Aim 1: To elucidate the
molecular basis of the regulation of LAMP2A function in cystinosis. To this end, we will study the interplay
between the CTNS protein and the CMA receptor LAMP2A and elucidate the mechanisms that mediate LAMP2A
trafficking and destabilization at the lysosomal membrane in cystinosis. Aim 2: To determine the molecular basis
of the regulation of CMA activity in cystinosis. We will study the mechanisms mediated by CTNS to regulate
CMA function and will test the hypothesis that the rescue of CMA activity improves the function of proximal tubule
cells from cystinotic patients. Aim 3: To utilize small-molecule CMA activators, in vivo, to improve renal function
in cystinotic mice. We will correct cellular and renal function in cystinotic mice using CMA activators, alone, or in
combination with cysteamine. Our research is highly significant because it aims to elucidate molecular
mechanisms associated with a devastating human pathology and will help develop new therapies for the
treatment of cystinosis and other human diseases.

Public health relevance
PROJECT NARRATIVE Lysosomal storage diseases are caused by genetic defects leading to anomalous accumulation of metabolites in lysosomes, the degradative and recycling compartment of the cell. These toxic products, when accumulated in large amounts, can be harmful to humans. The identification of novel mechanisms that regulate autophagy and compounds that improve cellular and organ function would lead to novel treatments for several human diseases including lysosomal storage disorders.